Neural Imaging Module

Project Summary
Current vision research relies on a wide variety of imaging techniques and modalities, ranging from MRI-based
imaging of the living brain, to detecting a neuronal tracer, to reconstructing neurons that have been
histochemically processed. However, the resources and expertise required for the wide range of such
techniques can often lie outside the scope of individual laboratories. The Neural Imaging Module aims to
address this need by providing extensive support to investigators using both pre- and post-mortem techniques
to visualize brain tissue. Specifically, the Neural Imaging Module (1) supports pre-mortem studies in monkeys,
such as fMRI and CT scan-based methods for guiding physiological experiments; (2) assists with post-mortem
experiments in rodents and monkeys, including staining for specific neuronal markers, assessment of post-
physiology electrode tracks, and testing of new viral-based tracing techniques; and (3) provides tools and
services for analysis of histological preparations, including alignment of serial sections, and reconstructions of
neurons and projections. In keeping with the diverse nature of these services, the Module has contributed to a
wide variety of vision-based investigator projects. Under the experienced direction of Module Director, Dr.
Richard Born, and Module staff member Dr. Vladimir Berezovskii, the expertise and services provided by the
Neural Imaging Module will continue to play a critical role in advancing Harvard-area vision research.